Preclinical Evaluation of Anti-Fibrin Immunotherapy for Cerebral ALD: Leveraging a Novel Mouse Model to Guide Clinical Trial Design

X-linked adrenoleukodystrophy (ALD) is a devastating genetic disorder, caused by mutations in a peroxisomal
gene (ABCD1), in which two-thirds of affected males develop cerebral ALD (cALD), a progressive, inflammatory
brain condition that is often fatal. Currently, the only available treatments are hematopoietic stem cell
transplantation (HSCT) and ex vivo gene correction (FDA-approved in 2022). However, these therapies are
limited to a subset of cALD patients based on factors such as lesion stage, age, donor availability, and access
to advanced healthcare facilities. Consequently, most boys and men worldwide who develop cALD die from it.
We propose using a novel cALD mouse model to test a first-in-class, monoclonal antibody therapy targeting
fibrin, a potent pro-inflammatory protein that is highly expressed in cALD brain lesions. Fibrin, a hallmark of
blood-brain barrier (BBB) disruption, plays a crucial role in neuroinflammation and demyelination by activating
macrophages, microglia, and astrocytes, and impairing oligodendrocyte maturation.
Our approach leverages our recently developed mouse model which combines cuprizone (CPZ) diet and
MOG injection (EAE model) in Abcd1-knockout mice to induce a cALD phenotype. Our model replicates key
features of human cALD, including demyelination, axonal damage, BBB disruption, oxidative stress, and fibrin
deposition. We will evaluate the efficacy of 5B8, an antibody targeting fibrin's pro-inflammatory epitope (amino
acids 377-395), in alleviating neurological disability and reducing pathological manifestations in cALD mice. We
will compare the effect of therapy in early (presymptomatic) and late (symptomatic) stages of the disease and
against sham IgG control.
The project comprises three aims:
In Aim 1, we will investigate whether anti-fibrin immunotherapy ameliorates behavioral symptoms by assessing
motor function using the open field test and cognitive function using the Barnes maze.
In Aim 2, we will examine whether anti-fibrin immunotherapy improves BBB disruption in the brain using T1-
weighted MRI and increases cerebral blood flow using Arterial Spin Labeling MRI in the cALD mouse model. We
will also analyze plasma biomarkers of BBB disruption and neuroinflammation, including neurofilament light
chain, interleukin-18, vascular cell adhesion molecule 1, and other markers.
In Aim 3, we will confirm target engagement and evaluate whether anti-fibrin therapy reduces histological brain
lesions by performing immunostaining to measure BBB integrity, immune cell infiltration, and axonal damage.
The successful completion of these aims will generate necessary preclinical data and identify relevant
biomarkers to facilitate the design of a Phase 2/3 human clinical trial for anti-fibrin immunotherapy in cALD.
Success could lead to a novel treatment option for this devastating disorder, addressing a serious unmet medical
need and offering hope for patients currently ineligible for existing therapies.

Public health relevance
X-linked adrenoleukodystrophy (ALD) is a devastating genetic disorder caused by mutations in the ABCD1 gene, often leading to fatal cerebral ALD (cALD), with current treatments limited to a subset of patients. This study proposes using a novel cALD mouse model to test a first-in-class, monoclonal antibody therapy targeting fibrin, a pro-inflammatory protein highly expressed in cALD brain lesions. The research aims to evaluate the efficacy of this therapy in alleviating neurological disability and reducing pathological manifestations in early and late stages of cALD, with the goal of generating necessary preclinical data and identifying relevant biomarkers to facilitate the design of a Phase 2/3 human clinical trial.